Flow Cytometry

Flow cytometry is a critical tool for cancer research. It is used to identify, track and purify specific cell populations, assess cell cycle progression and apoptosis responses, and to support a broad range of engineering approaches such as the quantification of delivery systems and the development of novel protein labeling and imaging technologies. The Koch Institute Flow Cytometry Core is a Shared Resource that provides Center Members training in, and access to, state-of-the-art instrumentation, data analysis and technical expertise in cell sorting and analyses. In the current period, the capabilities of this Core were further expanded and enhanced. This includes moving into a larger, custom-designed space in the new Koch Institute building, an increase in the Core staff and the acquisition of new instrumentation. Notably, in the same period, there has been a substantial increase in the number of Center Members who use the Flow Cytomtery Core from 78% to 94%, including investigators from all four Programs. Thus, this Shared Resource is essential to the success of the Koch Institute mission. In the upcoming period, the Flow Cytometry Core will continue to offer a wide range of state-of-the-art services to support the research programs of Center Members. Additionally, the Core plans to make new instrument purchases, with the support of MIT funds, and establish cutting edge single cell technologies, with the support of requested developmental funds. In spite of the major expansion in services and the resulting increased costs of running this Core, the requested CCSG budget for Year 44 is slightly reduced from the requested and recommended budget in Year 39.